Project 5 - Effects of Nursing Home Payment on Patient-Centered Outcomes for Older Adults and People with ADRD

OTHER PROJECT INFORMATION – Project Summary/Abstract
Project 5 – Effects of Nursing Home Payment on Patient-Centered Outcomes for Older Adults and People
with ADRD
Nursing homes provide care to millions of older adults annually, half of whom have Alzheimer’s disease and
related dementias (ADRD). Yet many homes are unable to deliver high-quality care, putting patients’ health at
risk. One potential policy to address inadequate quality and safety is to raise payment rates for these facilities,
thereby encouraging facilities to employ more resources and treat more patients, for instance through increased
nurse staffing. This project takes advantage of 2010 and 2019 reforms that overhauled Medicare’s skilled nursing
facility (SNF) payment system, changing the payments for thousands of facilities (homes) by 5% or more. The
project will leverage these reforms as natural experiments to study the relationship between payment rates and
nursing home access and quality. Our rigorous empirical strategy, already validated in a study on hospital
payment, uses a simulation approach to predict each nursing home’s change in payment rates from each reform.
The method processes pre-reform patients under post-reform payment rules and then uses instrumental
variables differences-in-differences models to assess the impacts of payment rates on patient-centered
outcomes, tracked in detailed assessment and claims data. Through these data, we can measure direct effects
on Medicare patients as well as indirect effects on long-stay Medicaid and private-pay patients. The project will
show how SNF payment rates affect access to care and patient-centered outcomes in Medicare; measure effects
on key quality of life outcomes such as depression, behavior, and cognitive function; analyze the mechanisms
driving these effects by assessing impacts on resources for care, such as nurse staffing; study patient outcomes
due to shocks such as seasonal influenza to better understand whether payment contributes to SNF
preparedness for infectious disease outbreaks, including COVID-19; consider the “spillover” effects of Medicare
payment on long-stay patients who were not the target of the reform; and consider how payment affects
racial/ethnic and other socioeconomic disparities. The project adds to the P01 research plan a fifth major
influence on healthcare – provider payment rates – and in an additional care setting – nursing homes. It considers
the effects of policy in a crucial setting where care is delivered to people living with ADRD and an important
potential cause of disparities in access and outcomes.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative Nursing homes are key sources of care for millions of older adults, especially those with dementia, but many facilities are unable to consistently deliver high-quality care for these vulnerable patients. To explore the role of payment rates as a tool to address these gaps in quality, this project leverages two recent Medicare nursing home payment reforms as natural experiments. We consider the effects of payment on the quality and safety of care for skilled nursing patients, the mechanisms like staffing that drive these effects, “spillover” effects onto long-stay patients, and the implications of payment changes for disparities in care access and quality. These results will show the benefits and potential unintended consequences of payment reforms and guide future efforts to improve healthcare quality and value for people with dementia and other older adults.